Probing Regional Metabolism During Exercise through Coronary Sinus Sampling

PROJECT SUMMARY/ABSTRACT
Despite advances in our management of patients with heart failure with reduced ejection fraction (HFrEF),
substantial residual morbidity and mortality continues to plague the contemporary treatment era. A hallmark
feature of HF remains reduced exercise capacity, which is associated with substantially reduced quality of life.
A growing appreciation for interventions that alter metabolism to improve HF pathobiology has accumulated in
recent years. Through his K23 application, Dr. Selvaraj is currently investigating the role of therapeutic ketosis
to modify exercise capacity in HFrEF. Noting both cardiovascular and peripheral limitations to exercise
observed in HFrEF, techniques to dissect regional metabolic changes are pivotal to understanding metabolic
modulation as a treatment principle. To decipher local metabolic changes, arteriovenous sampling is a
powerful technique which measures metabolic gradients across muscle beds. For example, coupled with
arterial access, catheters in the coronary sinus and femoral vein can be used to calculate fuel uptake and
secretion in the heart and legs, respectively. This feasibility study through an R03 mechanism seeks to
implement arteriovenous sampling of the heart and leg to determine changes in metabolite utilization during
submaximal (constant-intensity) exercise. This collaborative team will leverage interventional cardiologists and
electrophysiologists (who routinely access the coronary sinus during clinically indicated procedures) to perform
blood sampling among patients referred to the cardiac catheterization laboratory at Duke University Hospital, a
high-volume center for diagnostic catheterization. Aim 1 will assess the feasibility of coronary sinus sampling in
10 patients during low/moderate constant-intensity exercise. Aim 2 will determine time-dependent metabolite
trajectories after the cessation of exercise from the coronary sinus. Dr. Selvaraj, an early career investigator
and Assistant Professor at Duke University, has a long-term goal of becoming an independently funded
cardiovascular researcher with a focus on cardiovascular metabolic interventions in HF and using deep
phenotyping techniques to define pathways of benefit. Achievement of these aims will position Dr. Selvaraj to
investigate regional metabolism with metabolic interventions. Furthermore, the technique can be leveraged for
other ‘omic platform analysis to comprehensively assess myocardial and skeletal muscle biology during
exercise.

Public health relevance
PROJECT NARRATIVE Patients who have heart failure, or the inability of the heart to pump blood efficiently to the body, have reduced quality of life, exercise intolerance, and are at greater risk for poor outcomes including death. This proposal seeks to understand how much sugar, fat, and ketones the heart and legs use during exercise. If successful, these results will allow us to further understand how changes in dietary consumption or medications change what the heart and legs use for energy during exercise in future studies and identify new ways to improve exercise tolerance in heart failure.